Leveraging Genomic Diversity to Promote Animal and Human Health

ABSTRACT Support is requested for a Keystone Symposia conference entitled Leveraging Genomic Diversity to Promote Animal and Human Health, organized by Drs. Michèle Ramsay, Han Brunner and Appolinaire Djikeng. The conference will be held in Kampala, Uganda from November 25-29, 2018. Genomic variation is a driving force of animal and human health and susceptibility to disease, but our focus rarely spans human ethnic genomic diversity and genomic variation between animal breeds, limiting their translational impact. This symposium aims to: 1) Highlight translational genomics in humans and animals (clinical medicine and animal breeding for health and productivity), 2) Explore synergies and cross-disciplinary learning, 3) Explore opportunities to leverage genomic diversity to push the current boundaries to translation, and 4) Address translation and affordability in low- and middle-income settings. Large-scale genomics initiatives like Genome England, the US Precision Medicine initiative, and the Human Heredity and Health in African Consortium, are providing extraordinarily large data sets to explore useful genotype-phenotype connections. Equivalent initiatives for animal data are starting. This meeting will explore the translation of genomic research in animals and humans; high and low-resourced environments; ethnic diversity; and cultural context. Identifying common themes in animal and human health opens up opportunities for repurposing of ideas and applications, and for finding innovative solutions for translational genomics through cross-boundary communities of practice.

Public health relevance
PROJECT NARRATIVE Genomic variation is a driving force of animal and human health and susceptibility to disease, but our focus rarely spans human ethnic genomic diversity and genomic variation between animal breeds, limiting their translational impact. This Keystone Symposium is timely as researchers, clinicians, commercial companies and other users (i.e., animal breeders) are applying their minds to translational genomic science with the aim to develop tangible outcomes to enhance diagnosis, understand treatment responses, develop targeted therapeutics and develop potential preventative interventions for diseases spanning animal and human health.